Development of an Oral Methionine-Gamma-Lyase Enzyme for the Treatment of Homocystinuria

Abstract - Development of an Oral Methionine-Gamma-Lyase Enzyme for the
Treatment of Homocystinuria
Syntis Bio is developing Syn-202, a novel methionine gamma-lyase (MGL) enzyme therapy
aimed at correcting the metabolic dysregulation in Homocystinuria (HCU), a rare pediatric
disorder caused by mutations in the cystathionine-β-synthase (CBS) enzyme. This genetic
defect leads to the toxic accumulation of methionine and homocysteine, disrupting critical
metabolic pathways and resulting in severe neurological symptoms, developmental
impairments, and life-threatening metabolic crises. Current treatments, which primarily rely
on dietary methionine restriction, are challenging for young children and patients in
resource-limited settings to adhere to, leading to poor compliance and poor outcomes. Syn-
202 offers a more effective and patient-friendly alternative by enzymatically replicating the
effects of dietary methionine restriction in a convenient oral formulation. Additionally, Syn-
202 is engineered for proteolytic and pH stability, overcoming the delivery challenges that
often limit the efficacy of oral biologics, ensuring consistent and reliable activity.

Public health relevance
Project Narrative Syntis Bio is developing Syn-202, a first-in-class, protease-resistant methionine gamma- lyase enzyme for the treatment of Homocystinuria (HCU), a rare pediatric metabolic disorder characterized by toxic homocysteine accumulation.